Preventing and Reversing Interstitial Fibrosis in HFpEF

Heart failure with a preserved ejection fraction (HFpEF) is an increasingly prevalent problem and particularly so
amongst an aging Veterans population. It accounts for over half of all patients with heart failure. While there
have been considerable advances in understanding the mechanisms and treatment of patients with heart
failure when ejection fraction is reduced, there have been few advances in understanding the mechanisms or
treatment of HFpEF. From a clinical standpoint, the prevalence of comorbid conditions such as obesity,
diabetes, COPD and hypertension in these patients has led to the inflammatory hypothesis where HFpEF is
also associated with coronary microvascular dysfunction. Nevertheless, the causal importance of inflammation
and impaired coronary flow regulation in the development of the HFpEF phenotype remain unclear. Advances
in understanding mechanisms of HFpEF have been limited by the lack of suitable animal models of disease.
At present, the only available models involve uncontrolled chronic hypertension with severe left ventricular
hypertrophy (LVH). While these have informed our understanding of hypertensive heart disease and diastolic
dysfunction over the last 50 years, they may not be directly relevant to the majority of HFpEF patients. First,
most patients with HFpEF have controlled or only mild systolic hypertension and LVH is frequently absent.
Second, in contrast to patients with HFpEF, hypertensive heart disease progresses to systolic dysfunction
(HFrEF). Thus, how the development of reduced left ventricular compliance typical of many HFpEF patients
develops in the absence of sustained hypertension remains an enigma. Completed work during the previous
funding period has resulted in the development of a large animal model of the HFpEF cardiac phenotype
produced by repetitive brief LV pressure overload. This simulates the labile systolic hypertension typical of
patients with reduced systemic arterial compliance accompanying aging where HFpEF is particularly prevalent.
Initially, brief pressure overload is characterized by stretch-induced “stunning” with focal myocyte apoptosis
and troponin I release occurring in the absence of myocardial ischemia. Within 2-weeks, reduced LV
compliance, myocyte loss and myocyte cellular hypertrophy develop with a prominent increase in interstitial
fibrosis. This is accompanied by concentric inward LV remodeling yet, like most patients with HFpEF, the
absence of severe left ventricular hypertrophy or uncontrolled hypertension at rest. The central hypothesis of
this proposal is that stretch-induced myocyte injury associated with repetitive labile systolic hypertension and
preload elevation leads to chronic troponin I release and a myocardial inflammatory response that is initiated
by proinflammatory macrophages. This leads to myocyte loss and to the development of interstitial fibrosis.
This progression can be prevented by interventions that attenuate fibrosis and the macrophage response to
chronic myocyte injury. We will use the swine HFpEF model to translate three promising antifibrotic
interventions that are supported by mechanistic studies in rodent models of cardiac fibrosis but not translated
to a large animal model of disease. Aim 1 will test the hypothesis that the development of the HFpEF
phenotype can be prevented by limiting the recruitment of proinflammatory macrophages following repetitive
pressure overload-induced myocyte injury with micelles loaded with a CCR2 inhibitor. Aim 2 will test the
hypothesis that N-Acetyl-Seryl-Aspartyl-Proline (Ac-SDKP), a peptide inhibitor of fibrosis, can reverse
established interstitial fibrosis and improve left ventricular compliance by attenuating the macrophage
response to myocyte injury. Aim 3 will test the hypothesis that intracoronary cardiosphere derived cells can
promote macrophage polarization to a reparative phenotype and improve LV compliance by reversing fibrosis
as well promoting myocyte proliferation. Our long-term objective is to improve the care of Veterans with heart
failure by developing a better understanding of the mechanisms leading to HFpEF and identifying novel
targeted treatments that can prevent or reverse interstitial fibrosis to increase LV compliance.

Public health relevance
Cardiovascular disease is the leading cause of death among Veterans and congestive heart failure is among the most common conditions resulting in death, disability and hospitalization. With aging along with prevalent risk factors such as diabetes, COPD, obesity and hypertension, heart failure with a preserved ejection or, HFpEF, now equals the incidence of heart failure with a reduced ejection fraction or HFrEF. While we have made great advances in the drugs and devices available to treat HFrEF, they don’t work in HFpEF and diuretics remain the only therapy available to treat the increasing number of patients with this condition. The research proposed in this application will attempt to fill this critical gap in therapy by studying three therapies shown to reduce cardiac fibrosis in a preclinical model of HFpEF having many similarities to humans with this condition. A therapy that reverses cardiac interstitial fibrosis could improve filling of the left ventricle and have a major impact on symptoms, disability and survival of Veterans with this common condition.